Administration and Management of the Resource for Native MS Guided Structural Biology

Project Summary: Administration and Management. The proposed Resource for Native Mass
Spectrometry Guided Structural Biology ( ) brings together a team of outstanding scientific
nMSSB Resource
leaders who, with the support of select staff, postdoctoral researchers, and graduate students, are well-equipped
to collaboratively advance the proposed science, dissemination, and training. This team will work together to
produce an integrated workflow for structural characterization of protein:protein, membrane protein:lipid, and
RNA:protein complexes. The proposed characterization workflow will lead to a better understanding of how
protein complexes carry out their normal biological functions, how alterations in architecture lead to disease, and
how to build synthetic mimics to carry out desired biomedical applications. Through integration of all components
of the
nMSSB Resource
(TR&Ds, DBPs, and Community Engagement), we will steer conversion of the
developed native MS workflow from an appealing technology used by specialists and their collaborators to a
widespread frontline tool that can be used to guide other biochemical and structural tools.
The overall goal of the Administration and Management Core is to ensure that the vision of the Resource
for Native Mass Spectrometry Guided Structural Biology,
nMS  SB Resource
, is achieved by supporting the
TR&D projects, the DBP portfolio, and the Community Engagement mission. The proposed
nMS  SB Resource
will develop a native mass spectrometry characterization workflow that will quickly provide structural information
on protein complexes that are not amenable to, or not yet at a stage appropriate for, other complementary high-
resolution structural biology tools. The data (m/z, stoichiometry, heterogeneity, connectivity, topology, and
relative subunit binding strengths of protein complexes) will be acquired relatively quickly, on samples that are
not highly purified, and on smaller sample quantities than required for most traditional tools. A broad user
community will be trained and results disseminated by presentations, publications, and device installations, with
a long-term goal of technology commercialization (integrated surface-induced dissociation with high resolution
ion mobility and UV photodissociation). Meeting these combined goals requires effective administration and
management as described in the three aims below.
 Aim 1. Define an organizational structure and staff responsibilities that provide scientific leadership,
direction, and coordination to foster communication and collaboration among the Resource components.
 Aim 2. Define resource operating procedures, working with the external and internal advisory committees
to ensure sound fiscal management and efficient administrative support to all Resource components.
 Aim 3. Assess the effectiveness of the Resource and its progress toward sustainability. Dissemination
efforts through training, short courses, workshops, and publications, installations of devices, and vendor
commitments to support beta installations and commercialize, are key measures of sustainability.